Mapping of the IgM and IgG antibody responses to Talaromyces marneffei infection in mice and humans - Deciphering acute from reactivated or latent infections

Abstract
Talaromycosis is an invasive mycosis caused by the dimorphic fungus Talaromyces marneffei (Tm) endemic in
Southeast Asia. Infection kills one in three infected people with a compromised immune system, and is the
leading causes of HIV-associated death in the endemic region. Current diagnostics can only identify the fungus
in late stage infection. We know infection can reactivate up to 7 years from exposure in returning travelers, but
we lack an antibody test to determine who has been infected and who has a primary versus a reactivated
infection. We and other have documented a 30-70% increase in cases during the rainy humid months in multiple
countries. Our epidemiology studies suggest that this remarkable seasonality is due to acute exposure leading
to acute primary infections rather than alterations in host factors. Our human cohorts, including the IVAP clinical
trial, have shown that patients who present with an acute pulmonary syndrome have a shorter duration of illness
and rapidly progressive fatality. Our central hypothesis is that the acute pulmonary form of infection has a more
virulent pathogenesis than the reactivated form, and host IgM and IgG patterns can differentiate between these
forms. We propose two related but independent aims to test this hypothesis.
AIM 1. To validate the novel anti-Mp1p IgM and IgG enzyme immunoassay (EIA) and to delineate the
impact of acute primary infection on patient outcomes. Here, we will leverage the IVAP trial biorepository
with longitudinal plasma samples (6 timepoints collected over 24 weeks) from 440 culture-confirmed
talaromycosis patients to map the IgM and IgG responses in humans, identify the IgM/IgG serological pattern
associated with acute infection, and determine the impact of acute primary infection on patient outcomes.
AIM 2. To develop a novel murine pulmonary model to decipher the host anti-Tm antibody responses to
primary versus reactivated infection. Here, we will develop a novel pulmonary model using non-invasive
oropharyngeal aspiration and low infection inoculum to mimic natural human infection. We will develop an acute
primary infection model in CD4-depleted mice and develop chronic infection in immunocompetent mice, followed
by CD4 depletion to induce a reactivated infection model. Our goal is to understand how a mammalian antibody
response should differ between primary versus reactivated infection and use the mouse antibody data to
strengthen the interpretation of antibody responses in humans.
Impact. Our studies aim to establish a serological diagnosis for talaromycosis which has the potential to
differentiate acute from reactivated infection and expand our knowledge of disease spectrum. The new murine
pulmonary model will facilitate new research into the host immune response to Tm infection. The antibody test
will enable population-based seroprevalence studies to advance our understanding of disease burden,
geographic risk, latency, and risk populations. This knowledge will inform both disease management at the
individual level and prevention strategies at the population level.

Public health relevance
Talaromyces marneffei is a fungus endemic in Southeast Asia that kills one in three infected persons with a compromised immune system, particularly those infected with HIV. We propose to use samples from a large clinical trial to validate a new antibody test and develop a mouse model mimicking natural human infection to generate antibody data from mice to decipher antibody data in humans. Our studies have the potential to enable clinicians, for the first time, to tell primary from latent forms of infection and help identify people with asymptomatic infection to guide disease control and management.